A Scalable Continuous Production Platform for Large-Scale Manufacturing of Therapeutic Exosomes

Project Summary
Exosomes are a subset of extracellular vesicles, with diameters between 30 and 200 nm, secreted by
most eukaryotic cells. They deliver bioactive cargos, such as lipids, proteins and nucleic acids, to other
target cells. Tremendous effort has been made recently on developing highly specific exosome-based
drug delivery systems. Yet, there remain fundamental challenges: 1) current technologies for exosome
enrichment and isolation cannot achieve sufficient throughput or purity; 2) drug loading efficiency into
exosomes is very limited; and 3) the production of exosomes has yet to reach sufficient high throughput
for clinical tests or even further development. To address these challenges, the proposed project utilizes
a three-dimensional (3D) piezoelectric scaffold (PES) to stimulate exosome production, a lipid-
membrane penetrating chiral graphene quantum dots (GQD) for efficiently load drugs into exosomes
(>70% yield) and a scalable tangential-flow ultrafiltration module with ion-track asymmetric nanopore
membranes (ANM) to isolate exosomes with high yield (>85%), throughput (240 mL/hour per module)
and purity. The integration of three modules constitutes a high-throughput, high-purity, and scalable
integrated platform for continuous manufacturing of therapeutic exosomes. The project is based on PI
Wang’s preliminary experimental and computational results that GQDs facilitated drug loading into
exosomes with higher efficiency than any current method, her extensive experience on nanocomposite
for 3D tissue cultures, the co-PI Chang’s ANM exosome isolation technology for liquid biopsy and his
patented technology on high-throughput AC nanofiber electrospinning. We will achieve the goal by
following specific aims: 1) Develop high-throughput exosome production bioreactor module with
stimulating PES. 2) Develop high-efficiency exosome drug loading module with chiral GQDs. 3)
Develop and establish continuous ANM isolation and purification module. The proposed project
contains several innovated approaches of exosome production, loading and isolation, if successful and
integrated, can enhance therapeutic exosome production rate over current design, and achieve
continuous production of therapeutic exosomes. Such an integrated production pipeline provides an
innovative high-throughput and high-purity exosome manufacturing platform for drug delivery. They will
also be designed to allow easy scale up for reactors of arbitrary size or for effluents from multiple
reactors. Scaling to higher throughput can be achieved by just adding more parallel lines of the same
modules.

Public health relevance
Project Narrative Tremendous effort has been made recently on developing highly specific exosome-based drug delivery systems. The proposed project utilizes a three-dimensional piezoelectric scaffold to stimulate exosome production (up to 50-fold), a lipid-membrane penetrating chiral graphene quantum dots for efficiently loading drugs into exosomes (>70% yield) and a scalable tangential-flow ultrafiltration module with ion- track asymmetric nanopore membranes to isolate exosomes with high yield (>85%), throughput (240 mL/hour per module) and purity. Integration of the three modules constitute a high-throughput, high- purity and scalable integrated platform for continuous manufacturing of therapeutic exosomes.